Paternal Contributions to Metabolic Disease in Offspring: Environment, Epigenetics, and Sperm

PROJECT SUMMARY
One novel approach to reduce the burden of type 2 diabetes and obesity comes from the recognition that parental
obesity or diabetes can increase risk of metabolic disease in offspring via non-genetic effects. This perspective
raises the exciting possibility that treatment of parents to improve their metabolism before conception could
interrupt vicious intergenerational cycles of obesity and diabetes, thus improving offspring health.
In the prior funding cycle, we developed evidence for the impact of paternally-focused interventions on the sperm
epigenome and offspring health. We recently demonstrated in humans that paternal obesity is associated with
altered DNA methylation in cord blood of offspring7. Our new data in mice indicate (1) paternal obesity and
hyperglycemia are key determinants of offspring health, (2) improving paternal metabolism - by treatment with
either SGLT2 inhibitors or caloric restriction - can reverse age-associated weight gain, insulin resistance, glucose
intolerance, and fatty liver in F1 offspring, (3) paternal metabolism potently modifies the transcriptome in fetal
and adult offspring, including oxidative and lipid regulatory genes, and (4) paternal metabolism alters the
epigenome in both sperm and offspring tissue. For example, DNA hydroxymethylation (5hmC) at enhancers
adjacent to differentially expressed genes is reduced in sperm of HFD-fed males, and reciprocally increased in
males treated with SGLT2i or the AMP kinase activator AICAR.
In this revised application, we will utilize this innovative mouse model to identify the mechanisms by which
paternal health and its treatment modulate the paternal germ cell epigenome to improve offspring health, and to
test the hypothesis that the AMPK-Tet2 pathway, a mediator of glucose-mediated epigenetic regulation,
mediates observed differences in sperm 5hmC and offspring metabolic disease. In Aim 1, we will define the
impact of paternal obesity and hyperglycemia, and its reversal, on the germ cell epigenome (5mC/5hmC, small
RNA), and identify key cis-regulating elements. In Aim 2, we will determine the pathogenicity of germ cell
epigenetic changes by evaluating offspring outcomes after in vitro fertilization and sperm-derived ncRNA
injection. Aim 3 will determine whether paternal effects on offspring are mediated via direct effects on the embryo,
or on extraembryonic lineages affecting placental development, using single-cell transcriptomic analysis of
blastocysts at a single-cell level and detailed morphometric analysis of placentae derived from control, HFD, and
HFD+CANA-treated fathers. Aim 4 will test the hypothesis that the AMPK-Tet2 pathway, a mediator of glucose-
mediated epigenetic regulation in somatic cells, also mediates glucose-induced changes in the germ cell
epigenome. We will analyze the impact of AMPK activation in vivo on 5hmC in sperm from wild type or Tet2-null
mice and on offspring phenotypes. In summary, identification of causal mechanisms in response to paternal
hyperglycemia and obesity - and its reversal - will provide critical new information to guide development of new
paternally-focused translatable approaches to reduce disease burden in future generations.

Public health relevance
PROJECT NARRATIVE Recent information indicates that the health of fathers can influence the health of his offspring, via nongenetic (epigenetic) mechanisms. In this proposal, we will use a mouse model to test the hypothesis that paternal obesity and hyperglycemia can modify epigenetic marks in the sperm, and that these changes in sperm affect early life development and ultimately increase disease risk in offspring. Moreover, we will test whether using medications or dietary strategies to lower body weight and glucose in the father can improve health of offspring, and identify the mechanisms responsible for such changes.